Stress experiences as markers of person-level vulnerability and temporal risk for near-term suicidal ideation

PROJECT SUMMARY
Suicide is a leading cause of global mortality and rising suicide rates have been particularly steep in the United
States. Accordingly, NIMH is investing heavily in prevention, including calls for improved precision care—
interventions delivered based on specific, granular understanding of person-level vulnerabilities and their
interaction with local environments. Although stress, a well-established concurrent and prospective risk factor
for suicidal ideation (SI), is experienced by all, it varies at both group- (e.g., discrimination, local events) and
person- (e.g., arguments, accidents) levels in timing, frequency, and experience. Thus, there is a significant need
to improve the accuracy in detailing the stressful events – SI relationship, as well as elucidate person-level
markers that increase vulnerability to this association. Tonic (trait-like) and phasic (state) impulsivity (IMP) and
emotion dysregulation (ED) are well-established predispositions for suicide risk. IMP and ED alone are
insufficient markers of SI risk, yet each may increase risk for SI in the context of stressful life events. Their joint
effects may also potentiate the relationship between changes in person-level stress and risk for momentary SI;
however, this has yet to be tested, leaving little known about person-level, moment-to-moment SI prediction. The
overarching objective of this research is to specify person-level conditions that portend imminent SI, information
that has the potential to inform the development of effective just-in-time interventions, consistent with precision
care objectives of the NIMH Strategic Plan. This research will: (1) evaluate the direct effect of real-time stressful
events on concurrent and prospective momentary SI, (2) evaluate the moderating effects of tonic (trait-like) and
phasic (state) IMP and ED on the prospective relationship between real-time stressful events and momentary
SI, and (3) explore the propensity to experience SI in response to prior stress as a potential moderator of the
proximal relationship between real-time stressful events and momentary SI. A sample of individuals at high risk
for suicide (i.e., adults age ≥18 with persistent lifetime SI and SI during the past 6-months) will complete a
baseline session and 30-day period of ecological momentary assessment to evaluate tonic and phasic IMP and
ED, real-time stressful events, and momentary SI. Goals of the fellowship training plan, which will take place at
the University of Notre Dame, include: (1) enhance knowledge of emotional, personality, and cognitive
components of suicide risk; (2) develop advanced knowledge of the assessment of suicide risk factors; (3)
enhance knowledge of advanced statistical analyses for within- and between-persons research; (4) engage in
professional development activities and develop advanced research skills; (5) enhance knowledge of ethical
research practices with high-risk populations.

Public health relevance
PROJECT NARRATIVE Stressful events are a well-established risk factor for suicidal ideation, but a more granular understanding of when stressful events increase risk for suicidal ideation, as well as which person-level markers exacerbate this risk relationship, is imperative. This research will: (1) evaluate the direct effect of real-time stressful events on concurrent and prospective momentary suicidal ideation, (2) evaluate the moderating effects of trait and state impulsivity and emotion dysregulation on the stressful events – momentary suicidal ideation relationship, and (3) explore the propensity to experience suicidal ideation in response to prior stress as a potential moderator of this association. Findings of the proposed research will specify person-level conditions that portend imminent suicidal ideation, information that has the potential to inform the development of effective just-in-time interventions, consistent with precision care objectives of the NIMH Strategic Plan.